Hub4Smell: Advancing Human Olfactory Research through Digital Innovation and Community Engagement

PROJECT SUMMARY
The goal of this proposal is to launch and validate Hub4Smell, the first multi-test, collaborative, digital platform
designed to promote insights from human olfactory data. Hub4Smell will offer researchers and clinicians alike
two innovations: 1) customized tools for human olfactory data collection, curation, and analysis leveraging
generative AI; 2) access to private collaboration with experts to facilitate the use of smell testing and foster
engagement in olfactory research. This work lays the groundwork for shared research and data management
protocols in the current and future olfactory community across sectors (research, clinical, corporate), and offers
concrete support in the implementation of routine smell testing for the general population, in close alignment
with the NIDCD 2023 -2027 Strategic Plan and the Healthy People 2030 goals. This project leverages a
multidisciplinary team with expertise in digital health software development, generative AI and computer and
data science (Estenda); olfactory research and data interpretation (Monell); and commercialization of medical
devices, including olfactory ones (Ahersla Health). The three aims of this proposal are (1) to launch Hub4Smell
digital tools for collection, curation, and analysis of human olfactory data; (2) to develop a Hub4Smell online
community to share expert knowledge and foster engagement in olfactory research, and (3) to validate the
impact of smell testing on health outcomes and provider engagement via a large scale clinical trial. The project
promises significant advances: increased widespread access to high-quality research tools to expand the
reach of olfactory research, and expansion of the use of olfactory measurement and data quality. Altogether,
Hub4Smell offers tools, essential data, and infrastructure for achieving the public health benefits enabled by a
more complete assessment of human sensory function.

Public health relevance
PROJECT NARRATIVE Millions of people are experiencing smell dysfunction, which has a profound, unrecognized impact on health and economics. Lack of routine smell testing impairs research and clinical care in human olfaction. To advance human olfactory research and care we address these issues by launching and validating Hub4Smell, a collaborative digital platform that centralizes human olfactory data from various tests and users, provides insights through a generative AI exploratory module and grants access to expert knowledge, ultimately facilitating the adoption of smell testing in research and clinical settings.